Development of a novel, regenerative therapy to reverse synapse loss in Alzheimer's Disease

Project Summary/Abstract
The mission of the SBIR program is to “encourage domestic small businesses to engage in Federal
Research/Research and Development (R/R&D) that has the potential for commercialization.” A
mission of the NIA is to “support research on Alzheimer’s disease, and promote research on the
etiology, treatment, and diagnosis of AD”. The proposed development program is necessary to
enable the filing and acceptance of an IND with the FDA, an early prelude to commercialization.
The three specific aims of this development grant are:
1. GMP Manufacture of an oral dosage form of SPG302, a novel synaptogenic molecule.
2. Conduct GLP safety pharmacology studies and conduct GLP IND-enabling toxicology studies in
rats and Beagle dogs for 4 weeks with SPG302
3. Prepare and submit a successful IND request to the FDA.
The proposed studies are designed to optimize time and resources while moving step wise
through safety tests, resulting in an IND submission (for Phase 1 single ascending dose, multiple
ascending dose and food interaction studies) within 24 months of the grant being funded.
Spinogenix will work with a CRO to assemble the CMC, pharmacology and toxicology information
and to prepare and submit an electronic IND to the FDA.

Public health relevance
Project Narrative The proposed Direct to Phase II project is to undertake GMP manufacturing of drug product and GLP toxicology studies required for an IND submission to treat Alzheimer’s disease. With the assistance of a clinical CRO, Spinogenix will prepare and submit a successful IND to the FDA.